Disparities in Chronic Stress, QOL, and Physical Activity among Black and White Breast Cancer Survivors

Project Summary/Abstract – Project 2
Reports indicate Black breast cancer survivors have poorer health-related quality of life (HRQOL) than Whites,
although some studies suggest that Blacks have higher spiritual wellbeing. Several factors contribute to these
racial disparities in HRQOL. Data show that chronic life stress negatively impacts HRQOL. Chronic life stress is
defined as chronic psychosocial stress stemming from concerns about money, housing, job condition,
neighborhood environment, family situation, public services, crime and violence. Studies indicate a higher
prevalence of major life events for Blacks than Whites. In addition to chronic life stress, cancer-specific stress
(e.g. fear of recurrence) also affects HRQOL in breast cancer survivors. However, studies on HRQOL have
primarily focused on one measurement and longitudinal studies in Black breast cancer survivors measuring
stress and HRQOL at multiple time points have not been conducted. Physical activity is a key lifestyle factor in
healthy survivorship and better HRQOL after breast cancer. Despite data supporting physical activity’s beneficial
effect on chronic stress and quality of life, a lower percentage of African-American women meet recommended
guidelines for aerobic activity compared to Non-Hispanic Whites. The cumulative burden of chronic stress and
adverse behavioral responses (e.g. physical inactivity), may lead to increased “wear and tear” on the body’s
regulatory system, and exceed the body’s ability to repair its physiological systems. This pathophysiological
mechanism, known as allostatic load, is a marker of chronic stress and is influenced by the frequency and
severity of stressful events. Allostatic load is quantified through measurement of multiple physiological
indicators, including metabolic, immune and inflammatory markers. Understanding how allostatic load mediates
the relationship between perceived chronic stress (life stress and cancer-specific stress), physical activity and
HRQOL differentially among Black and White breast cancer survivors has not been determined. Our primary
goal is to investigate if chronic stress and physical activity are associated with HRQOL and racial disparities in
HRQOL among breast cancer survivors; and whether these associations are mediated by allostatic load. Among
Black and White female breast cancer survivors, our aims are to: AIM 1: Investigate the longitudinal relationship
between perceived chronic stress (life stress and cancer-specific stress) and HRQOL. AIM 2: Investigate the
longitudinal relationship between objectively-measured physical activity and HRQOL. AIM 3: Investigate
whether allostatic load is a mediator of the effects of chronic stress and physical activity (total energy expenditure,
duration, and sedentary behavior) on HRQOL.

Public health relevance
Project Narrative – Project 2 Black breast cancer survivors have poorer health-related quality of life than White survivors but the role of chronic stress and physical activity in these disparities have not been well-studied. Using the concept of allostatic load, that measures chronic stress markers in the blood, we propose to study disparities in quality of life in an effort to identify methods to reduce stress and improve the health of cancer survivors.